Sleep and Circadian Rhythm Disorders After Traumatic Brain Injury

PROJECT SUMMARY/ABSTRACT
Almost two million people sustain a traumatic brain injury (TBI) in the United States every year.
TBI is a contributing factor to one-third of all injury-related deaths, and more than 40% of
survivors suffer long-term impairments, including sleep and circadian rhythm disorders
(SCRDs). These disorders may underlie or exacerbate the lifetime elevated risks of metabolic
disorders, mood disorders, and neurodegenerative disease found in TBI patients. While the
prevalence of SCRDs has long been recognized in TBI patients and recapitulated in animal
models, the mechanisms underlying these disorders at the molecular and circuit levels are
unknown. This proposal exploits the Drosophila melanogaster genetic model to identify
genes that contribute to TBI-induced SCRDs and to determine the role of sleep in
mediating molecular and physiological outcomes of TBI. Based on published and
preliminary data, we hypothesize that TBI-induced inflammatory responses disrupt the circadian
and sleep regulatory systems in the brain, forming a positive feedback loop that prolongs
inflammation. We have established a tunable, head-specific Drosophila TBI paradigm that
results in chronic sleep reduction and reduced circadian rhythmicity of locomotor behavior after
injury. In this model, mild injury induces SCRD without affecting mortality. We seek to answer
two key questions: (Aim 1) What are the genetic drivers of sleep and circadian remodeling at
various phases after TBI? (Aim 2) Can interventions that target sleep and circadian disruption
after injury improve TBI outcomes? In Aim 1 we will conduct a candidate knockdown/knockout
screen of proinflammatory genes to identify genes that contribute to aspects of sleep and
circadian disruption after injury. In Aim 2 we will conduct the first comprehensive analysis of
sleep architecture changes after TBI in both sexes of flies. We will use this data to design a
paradigm of sleep manipulation at various phases after TBI to examine how sleep changes after
TBI affect longevity, locomotor function, and neuronal and glial health. To pursue these aims, I
will combine genetic tools for physiological characterization and for sleep manipulation as well a
behavioral assays available in the fly model. Use of a novel Drosophila TBI model will allow
unparalleled temporally and spatially controlled genetic manipulations to identify not only which
genes are important in SCRDs, but in what tissue(s) they act. The proposed study will be
impactful as it will define genetic pathways that link fundamental brain processes to TBI and
provide the foundation for future investigation with translational implications.

Public health relevance
PROJECT NARRATIVE Traumatic brain injury (TBI) contributes to one-third of all injury-related deaths in the United States, and the long-term complications resulting from TBI in survivors are complex and under-reported. These complications include dysregulated circadian rhythms and sleep disorders, which may underlie or exacerbate other elevated risks found in TBI survivors such as mood disorders, endocrine disorders, and neurodegenerative disease. The goal of this project is to identify genes that underlie TBI-induced sleep and circadian disorders and to identify interventions to improve sleep and circadian regulation after injury.